Molecular and morphometric imaging of coagulation and inflammation in pulmonary embolism pathogenesis

PROJECT SUMMARY
Pulmonary Embolism (PE) urgently requires improved diagnostic and therapeutic strategies to minimize both
acute complications resulting in hemodynamic shock and late complications encompassing possible progressive
pulmonary fibrosis, hypertension, and recurrent PE. Currently, fibrinolysis therapy of all PE does not provide an
overall net clinical benefit due to the increased risk of hemorrhagic stroke and fatal bleeding, aside from the
potential for unsuccessful fibrinolysis. To more accurately stratify and prognose intermediate-risk and low-risk
PE patients, a detailed understanding of the consequences of emboli composition, including its age, burden,
relevant cellular components, and post-PE inflammatory milieu, is needed. To address these unmet needs, this
proposal will utilize a novel murine model of PE in which the thrombi are formed in vivo in the deep veins of mice.
This model allows for direct control over thrombus age and size and the inclusion of the biological milieu during
thrombogenesis and aging. These thrombi are then embolized into the lung, resulting in PE. This model has
demonstrated a resident time of these emboli to be greater than 30 days, unlike previous published murine
models with emboli residence times up to 48 hours. To investigate the inflammatory and fibrotic response to PE
insult, we will utilize noninvasive longitudinal multiplexed molecular imaging evaluating specific agents for
neutrophils, macrophages, platelets, activated endothelial, epithelial, fibroblasts, type 1 collagen, and thrombin
activity. Translationally, we will quantify fibrin changes in various aged emboli pre- and post-fibrinolysis therapy
and its downstream effects on PE-induced inflammation and pulmonary fibrosis. Uniquely, this PE model allows
for the application of single nucleus molecular profiling across the proposal to examine the differences in
molecular signatures, cell composition, and cell-cell interactions associated with lung lobes with PE and those
lobes without PE from the same lung. This is important in uncovering the effects of PE-induced inflammation and
fibrosis that may drive the development of late PE sequelae, such as CTEPH and pulmonary hypertension.
Clinically translational imaging readouts tracking pulmonary artery pressures and right heart function in relation
to emboli size, age, and location will be correlated. Completion of the proposed work will provide a longitudinal
understanding of the influence of emboli age and size will be reported. Translation of these results may help
stratify PE beyond the acute high-low risk. It may help identify patients at a higher risk for late PE syndrome or
recurrent PE and highlight the usefulness of molecular imaging in the clinic, allowing for more bench-to-bedside
translation of preclinical molecular imaging agents.

Public health relevance
PROJECT NARRATIVE Pulmonary embolism (PE) is the third leading cause of cardiovascular death, with post-PE complications leading to drastic reductions in quality of life and chronic functional limitations, as well as an increased risk of recurrent PE. This proposal will utilize a novel murine model of PE, single nucleus molecular profiling, and longitudinal multiplexed molecular imaging to noninvasively access the contribution of PE size and age on the resultant inflammatory and pulmonary fibrotic response while also quantifying the salutatory effects of fibrinolysis therapy. These findings aim to elucidate novel targets and molecular imaging agents to aid in better diagnosis and stratification of patients with PE.